Active-site models unravel mechanism of enzymatic alkane activation

Project Summary
Archaea in the human gut express methyl-coenzyme M reductase (MCR) to catalyze the last step of
methanogenesis and the first step of the anaerobic oxidation of methane. These reactions occur at F430, a
nickel cofactor whose first coordination sphere — the ligands directly bound to it — includes the four nitrogen
atoms of a unique anionic macrocycle. This center reversibly cleaves the thioether methyl-coenzyme M (CoM–
SMe) to release methyl radical, which combines with thiol coenzyme B (HS–CoB) in the second coordination
sphere — the residues proximal to but not bonded to the active site — to liberate methane and the disulfide
CoM–S–S–CoB. The first and second coordination spheres of nickel in several MCR states are intractable,
which motivates us to synthesize tractable small molecules that recapitulate active-site features proposed for
these contentious states. Comparing data for models and MCR tells us how plausible these proposals are.
Our long-term goal is to synthesize high-fidelity models that help us understand how MCR makes and breaks
the C–H bonds in methane. Towards this goal, the objective of this project is to prepare, and spectroscopically
and chemically interrogate macrocyclic nickel complexes with very similar ligand environments to F430 in
different MCR states. The central hypothesis is that to mimic MCR spectroscopy a nickel complex needs a
high-fidelity first coordination sphere, while to mimic MCR function and cleave methane it further requires a
second-coordination-sphere radical. In preliminary work, we prepared and crystallized four-coordinate nickel
complexes of a readily tunable anionic macrocycle. Our density functional theory calculations predict that one
such complex should bind thiolate to mimic the first coordination sphere of F430 in the methane-cleaving step.
Further calculations predict that a related complex with a pendant thiyl radical near the thiolate is both plausible
and thermodynamically favored to cleave methane. The rationale is that tunable models will let us tease out
the motifs necessary for C–H activation. We will test our hypothesis by focusing on two specific aims. Aim 1:
Model the first coordination sphere of nickel in MCR to mimic spectroscopy and Aim 2: Model the second
coordination sphere of nickel in MCR to mimic function. Towards Aim 1 we will: (a) prepare and characterize
nickel complexes of anionic macrocycles, and (b) bind these complexes to water, thioether, thiolate, thiol,
methyl or hydride ligands. These ligands have been proposed to bind the MCR active site but evidence,
particularly for the last three ligands, is scarce, so our models will identify plausible first coordination spheres.
Towards Aim 2 we will: (a) further develop the nickel complexes to feature a thiolate and a proximal thiyl
radical, and (b) investigate the chemistry of this thiolate–thiyl species towards methane and other alkanes.
The macrocylic nickel complexes and their adducts will be the highest-fidelity synthetic models reported and
their activation of methane would be unprecedented for such nickel macrocycles. Overall, this work will
complement biochemical studies to fill in our mechanistic picture for MCR, a central metabolic enzyme.

Public health relevance
Project Narrative Our health depends greatly on a balanced gut microbiota, in which methanogenic archaea are sufficiently numerous to regulate hydrogen but not dominant to the point of causing gastrointestinal and metabolic diseases. Central to these archaeal energy metabolisms is methyl-coenzyme M reductase, a nickel enzyme that reversibly generates methane but does so through several intermediates with unknown active-site structures. Studying synthetic nickel complexes with high fidelity to the methyl-coenzyme M reductase active site will help us understand how methane is processed, and will teach us how to efficiently mediate C–H activation, a reaction that can expedite the syntheses of complex pharmaceuticals important to human medicine.